Contribution to the Standards and Trade Development Facility (STDF)

Grant Application Package
Cooperative Agreement to Support the Standards and Trade Development Facility (STDF)
Project Summary / Abstract
The STDF is a global partnership and trust fund that supports developing countries in building
their capacity to implement international sanitary and phytosanitary (SPS) standards, guidelines
and recommendations as a means to improve their human, animal and plant health status and
ability to gain or maintain access to markets. The STDF was established in 2004 by the Food
and Agriculture Organization of the United Nations (FAO), the World Organisation for Animal
Health (OIE), the World Bank, the World Health Organization (WHO) and the World Trade
Organization (WTO). Other organizations involved in SPS-related technical cooperation, donors
contributing funds to the Facility, and developing country experts also participate.
STDF's vision is that improved SPS capacity in developing countries supports sustainable
economic growth, poverty reduction, food security and environmental protection. Its mandate is
to: (i) increase SPS awareness, mobilize resources, strengthen collaboration, identify and
disseminate good practice; and (ii) provide support and funding for the development and
implementation of projects that promote compliance with international SPS requirements. In
achieving its aims, the STDF acts as both a coordinating and a financing mechanism. The
STDF is committed to the Paris Principles on Aid Effectiveness and to achieving the Millennium
Development Goals.

Public health relevance
Grant Application Package Cooperative Agreement to Support the Standards and Trade Development Facility (STDF) Project Narrative As a global partnership that assists developing countries to implement international sanitary and phytosanitary (SPS) standards, guidelines and recommendations, the STDF helps to strengthen the capacity of public and private sector stakeholders to implement Codex and other international standards, which contributes to improved domestic public health, as well as market access. More than one-third of STDF projects focus on improving the safety of food for domestic consumption and/or trade. The STDF also raises awareness about the importance of increased capacity to comply with international food safety standards, and the importance of this for public health.